Nebraska Center for Molecular Target Discovery and Development

Project Summary/Abstract: Overall Center Organization and Management Plan
The goal of the Nebraska Center for Molecular Target Discovery and Development is to establish and expand
physical and intellectual resources at the University of Nebraska Medical Center (UNMC) and the University of
Nebraska system that will catalyze the ability of its faculty to define, validate, and develop potential therapies
against molecular targets for clinically important diseases. The Center aims to maximize investment from both
the COBRE award and UNMC to enhance the research capabilities of the Institution, expand the translational
capabilities of its faculty, facilitate career advancement of promising junior faculty in the area of targeted
therapeutics, and efficiently drive discovery and development for the improvement of human health in
Nebraska and the nation. This Center will (1) create critical infrastructure for the discovery and validation of
molecular effectors critical to the development of disease and (2) deliver training and mentoring to promising
new investigators willing and able to use that infrastructure to validate those effectors as therapeutic targets,
identify small molecules for their manipulation, and create in vitro and in vivo preclinical models for their
development as novel therapies. Center investigators bring a breadth of cutting edge expertise necessary to
accomplish this vision. They share a common belief that many diseases can be effectively classified and
characterized through detailed genomic, genetic, and molecular analyses to identify drivers and vulnerabilities
from which will emerge unique therapeutic approaches. To realize this shared vision, the Center and its
investigators will: 1) Establish an Administrative Core and mentoring programs to support and enhance
research in target discovery and development; 2) Establish a critical mass of investigators focused on the
identification, validation and development of therapeutic targets for disease treatment; and 3) Increase
research capacity through scientific cores for high throughput chemical, RNAi and computational screening;
mass spectrometry; and target validation.

Public health relevance
Project Narrative: Overall Center Organization and Management Plan The goal of the Nebraska Center for Molecular Target Discovery and Development is to establish and expand physical and intellectual resources at the University of Nebraska Medical Center (UNMC) and the University of Nebraska system that will catalyze the ability of its faculty to define, validate, and develop potential therapies against molecular targets for clinically important diseases.